Deciphering the role of EYA3/PP2A in triple negative breast cancer metastasis

Breast cancer (BC) is one of the most diagnosed cancers in women (second only to skin cancer) and
comprises ~30% of all new female cancers each year. Nearly all BC-related deaths are caused by metastatic
dissemination. Triple negative breast cancer (TNBC), which is characterized by the absence of estrogen
receptors, progesterone receptors, and amplification of human epidermal growth factor receptor 2
(ER/PR/HER2), is highly metastatic, with poorer short-term survival than other BC subtypes. Because of the lack
of actionable targets, this subtype of BC has limited targeted therapies. Recent data suggest that TNBC is more
immunogenic than other BCs, due to its higher mutational burden. However, preliminary data from
immunotherapy trials have shown only modest responses in TNBC, likely because TNBC is a heterogeneous
disease, and can exhibit immunoreactive or immunosuppressive tumor immune microenvironments (TIME).
Thus, understanding molecular pathways that specifically contribute to TNBC are critical for developing new
therapeutic avenues. In this proposal we study the role of a critical developmental transcription coactivator and
phosphatase, Eya3, and its interaction with the B55α subunit of PP2A, in mediating breast cancer metastasis.
Eya3 is overexpressed in TNBC when compared to other BC subtypes, and we have previously demonstrated
that it enhances BC growth via a Myc-PD-L1 axis that suppresses CD8+ T-cell elimination of tumor cells.
Preliminary data in this proposal demonstrate that Eya3 does not only regulate primary tumor growth, but also
strongly, and specifically, regulates the TIME in the pre-metastatic niche and increases metastasis. Our
preliminary data further show that in addition to stabilizing Myc, Eya3 directly regulates NFkB signaling, which is
known to mediate inflammation and promote metastasis. In this proposal we will test the hypothesis that Eya3
mediates tumor progression not only by regulating Myc signaling, but also by directly regulating NFkB signaling
through a shared mechanism that requires an interaction between Eya3 and PP2A-B55α and leads to an altered
TIME. Understanding the molecular mechanism(s) by which Eya3 regulates PP2A function to alter two critical
cancer nodes may in the future lead to novel, less toxic means to target immune suppression and metastasis in
TNBC. To test this hypothesis, we will carry out two aims: 1) To determine the molecular and cellular
mechanism(s) by which the Eya3-NFkB axis enhances TNBC metastasis, 2) To determine the molecular
mechanism(s) by which Eya3 regulates NFkB signaling and whether this axis can be inhibited simultaneously
with the Myc axis. This proposal will enable us to understand how Eya3 promotes TNBC via enhancing the tumor
promotional, rather than suppressive, actions of PP2A. It will also set the stage for the exciting possibility that
direct inhibition of the Eya3/PP2A-B55a interaction may be an effective means to target two major tumor
promotional pathways that are difficult to target directly (Myc) or whose targeting leads to significant toxicities
(NFkB), as a means to enhance the adaptive and innate immune response to TNBC.

Public health relevance
We have identified a novel function for the transcriptional co-factor and phosphatase Eya3 in triple negative breast cancer (TNBC) metastasis, via regulating not only Myc, but also NFkB signaling, thereby influencing both adaptive and innate immune suppression. In this MPI proposal, we will use cell and molecular biology, structure/function analysis, and in vivo mouse modeling in immune competent settings to understand the role of Eya3 in activating NFkB to alter the pre-metastatic niche and increase metastasis, and to understand how the Eya3/PP2A interaction contributes to activation of these key oncogenic pathways. This work may lay the groundwork for potential inhibition of the Eya3/PP2Ainteraction as a therapy that could work with standard chemotherapies in TNBC, or work to enhance immune checkpoint therapies in this context.